The role of extracellular vesicles in keratoconus pathogenesis

PROJECT SUMMARY/ABSTRACT
Keratoconus is a chronic, lifelong corneal dystrophy and affects approximately 1:400 people worldwide,
including both males and females. Treating patients with advanced keratoconus has always been a challenge.
Corneal transplantation remains the gold standard for treatment, however, significant risk of postoperative
complications exist. Presently, keratoconus is diagnosed with specialized equipment and tests such as slit-lamp
and Pentacam®. Early diagnosis, where irregular astigmatism can complicate things, is critical for the
management of keratoconus. To-date, there are no biomarker tests which has consequently driven demand for
novel approaches to assist in the diagnosis, management and/or treatment of keratoconus.
Extracellular vesicles (EVs) are lipid bilayer-delimited particles released by cells, which may provide a
real-time snapshot of the entire cell/tissue/organ in a non-invasive way. EVs can regulate physiological
processes and contain components including proteins, miRNAs, DNA fragments, non-coding RNAs and lipids.
Therefore, EVs hold promise for the discovery of future biomarkers. In the context of corneal
diseases/dystrophies, tear fluid and tear EVs (tEVs) are the best candidate for biomarker investigations.
Surprisingly, very few studies have been reported (only Dry eye and Sjogren’s syndrome) investigating tEVs.
Our preliminary data provides strong evidence for the existence of tEVs in keratoconus patients that are
phenotypically different from their healthy counterparts. The proposed clinical studies aim to unravel the role of
tEVs in keratoconus pathobiology and discover relevant biomarkers associated with age, sex, and disease
severity. During our preliminary studies, we have recruited a small cohort of healthy and keratoconus patients,
and have put together a strong group of clinicians/collection sites that will assist us with sample collection during
the proposed period. Our data suggests significant phenotypic differences in the tEVs derived from keratoconus
patients, compared to healthy controls. We, therefore, propose an integrated multi-faceted “fingerprint” approach
that will include tEV physical characterization, proteomics, and miRNA profiling. We believe that our strategy can
shed light on future directions in this field for keratoconus diagnosis, management, and even treatment.
Relevance to Public Health – KC is a major clinical problem resulting in visual impairment worldwide. The long-
term implications of our study are important for KC patients since it could establish novel treatment modalities.
Ultimately, the ability to effectively, and safely, manage/treat all KC patients, is vital. The proposed work is novel,
translational, clinically relevant, and in line with NEI’s goals and research priorities to understand KC and develop
novel treatment options to reduce the burden of the disorder worldwide.

Public health relevance
PROJECT NARRATIVE Keratoconus (KC) disease is the degeneration of the corneal stroma, which causes the cornea to slowly change from its’ normal curved shape to a more conical shape, leading to vision distortion. The role of the KC tear fluid has been widely explored for biomarkers, however the presence and impact of the tear Extracellular Vesicles (EVs) remains unknown. The proposed studies have potential to discover novel biomarkers and pave the way for new diagnostic/treatment approaches.